Research Training in Pulmonary Immunology and Allergy at MGH

Research Training in Pulmonary Immunology and Allergy at MGH is a T32 renewal application that brings
together research programs of the Massachusetts General Hospital (MGH) Division of Pulmonary and Critical
Care Medicine (DPCCM), Allergy and Clinical Immunology Unit (ACIU), and Center for Immunology and
Inflammatory Diseases (CIID). This Training Program was created principally to provide comprehensive
training for physician-scientists in the DPCCM and ACIU fellowship programs interested in lung immunology
and allergic inflammation. The Program is designed to prepare the next generations of physician-scientists and
PhD-scientists to be leaders in lung immunology and allergy related research. In the first 3.5 years, this
Program has been highly successful with no unfilled slots and 100% academic retention. In addition, all of the
graduates of the Program have published at least one first-author publication and 73% have secured
independent funding. In this renewal application we capitalize on this success and momentum and provide
training in 10 scientific disciplines: (i) Adaptive Lung Immunity; (ii) Innate Lung Immunity; (iii) Allergic
Sensitization, Tolerance & Immunodeficiency; (iv) Lung Injury, Repair & Regeneration; (v) Molecular
Epidemiology & Genetics of Lung Disease and Allergy; (vi) Health Care Delivery Science in Pulmonary and
Allergy; (vii) Translational & Precision Medicine; (viii) Systems Biology, Single Cell Genomics & Epigenetics;
(ix) Microbiome; (x) Novel Imaging Modalities. The Program will have basic, translational, health outcomes and
epidemiology components. Specifically we seek to provide: 1) opportunities for mentored research in
disciplines that have the potential for high-impact discoveries; 2) outstanding research training through
didactics, seminars, and comprehensive mentoring; and 3) an environment and infrastructure that fosters
scholarly activity and career development into independent scientists. This application requests 10 training
positions that will be allocated to trainees who are committed to 2 to 3 years of research training. Eight MD or
MD/PhD candidates will be drawn from the highly competitive DPCCM and ACIU fellowship programs. Two
PhD trainees will be chosen from postdoctoral fellows in the laboratories of our mentors who are performing at
a high level and who have demonstrated a commitment to careers in pulmonary or allergy research. Two new
slots for PhD trainees are being requested based on trainee and mentor feedback indicating that our Program
would be strengthened, and the mission of the NIH better served, by having MDs and PhDs train side-by-side.
The 28 mentors in this Program were carefully chosen based on their track record of publications, grants,
mentoring, collaboration and interest in lung immunology and allergy. MGH provides an outstanding training
environment with over 1400 investigators, numerous training grants, research centers, trainee support groups,
and over $850 million in research grant awards. Furthermore, opportunities at Harvard Medical School, the
Harvard School of Public Health, and the Broad Institute provide additional valuable resources for trainees.

Public health relevance
Project Narrative Research Training in Pulmonary Immunology and Allergy at MGH is designed to prepare the next generation of physician-scientists and PhD-scientists who, through mentored research and rigorous training in new technologies, will be well prepared to be leaders in pulmonary immunology and allergy related biomedical research. The overall goal of the program is to educate trainees so that they can contribute to our understanding of the basis of inflammatory lung disorders and allergic diseases, and translate these findings to better clinical care for patients with these important diseases.